Linking rare primate ganglion cells to downstream visual functions

ABSTRACT
Retinal ganglion cells (RGCs) provide the sole source of visual information to the brain and form the building
blocks for all downstream vision. In primates, considerable progress has been made in characterizing the three
most common RGC types, which make up 80% of the retinal output, and much less is known about the remaining
15+ rarer RGC types. A key barrier to progress has been the difficulty of targeting these rare RGCs in acute
experiments. These challenges have been overcome with an approach for visualizing the structure and function
of foveal RGCs in the living macaque eye by combining calcium imaging, retrograde tracers and fluorescence
adaptive optics scanning light ophthalmoscopy (FAOSLO). FAOSLO imaging is non-invasive and enables study
of the same RGC populations for months or years. This technique has enabled in vivo classification of foveal
RGCs to identify the elusive rarer types. This proposal aims to extend the capabilities of FAOSLO imaging to
directly test the roles of these rare RGCs in vision while establishing the foundation for an independent research
career. Aim One will implement high-speed scanning strategies and voltage indicators to read the retinal code
in the living eye and achieve the temporal resolution necessary to study rare motion-sensitive RGCs. Aim Two
will directly test the hypothesis that the rare ON direction selective RGC type contributes to optokinetic eye
movements in primates using targeted laser lesions of individual RGCs. Aim Three will establish a paradigm to
isolate rare RGCs and the visual functions they mediate through transneuronal retrograde degeneration following
V1 lesions. This line of investigation will also clarify the timeline of RGC loss and the underlying physiological
changes that occur in RGCs following V1 damage in strokes. The research goals of this proposal are reinforced
by a comprehensive training plan that will provide the new skills and knowledge necessary to achieve the
candidate’s research goal of establishing the links between rare primate RGCs and visual functions. The
candidate will carry out the mentored phase with Dr. David Williams, a pioneer in the use of adaptive optics for
imaging the eye. Co-mentor Dr. Bill Merigan will contribute expertise in behavioral experiments, lesions and viral
vectors. Additional training from a first-rate advisory committee (Drs. Krystel Huxlin, Tony Movshon and Jesse
Schallek) will put the candidate on a strong pathway to independence. Together, the research and training
proposed will facilitate the candidate’s successful transition to a tenure-track faculty position at a research-
intensive university.

Public health relevance
PROJECT NARRATIVE The primate retina contains an incredible diversity of retinal circuits, the majority of which have not been characterized or integrated into models of primate vision. This project will use retinal physiology, circuit tracing and measures of behavior, all in the living macaque eye, to elucidate the roles of the rare retinal output neurons in primate vision, both in health and disease. The results will clarify the timeline of retinal degeneration following V1 stroke damage and the division of labor between the retina and the brain to inform techniques that seek to restore appropriate signals in the retinas of the blind.